Novel Stem Cell Immunotherapy for MDR-Tuberculosis

Abstract
Tuberculosis (TB) kills around 2 million people each year and is a major cause of mortality from a single
infectious disease worldwide. Emergence of multidrug-resistant TB (MDR) is now a major problem in
more than 60 countries of the world. MDR-TB is therefore a disease, where novel intervention strategies
including ‘therapeutic vaccines’ are required to supplement available drug regimen. A characteristic
feature of lung tuberculosis is the granuloma, which is collection of immune cells including T cells,
neutrophils, DCs, mesenchymal stem cells (MSCs) and macrophages (MФs) surrounding a central core
of Mycobacterium tuberculosis (MTB) infected macrophages (MФs). Granulomas restrict the growth of
MTB and continuously recruit immune cells. Macrophages are in turn, the major phagocytic cells which
kill MTB. We discovered two novel mechanisms through which MTB can be killed during tuberculosis.
First, we found that human pro-inflammatory M1-MФs expressed nitric oxide (NO) and up-regulated
autophagy to kill MTB whereas, anti-inflammatory M2-MФs allowed the growth of MTB due to a decrease
in NO synthesis and autophagy. Secondly, we discovered that, BCG vaccine and MTB infected
mesenchymal stem cells (MSCs) reprogrammed naïve human macrophages to become M1 phenotype
and more activated to kill MTB. Interestingly, Phase I trials using naïve, autologous MSCs have improved
the health of MDR-TB patients. In this proposal, we will leverage our new findings to increase human
macrophage activation through stem cell-mediated immunotherapeutic vaccine as follows. Specific Aim-
1: Investigate the molecular mechanisms through which, BCG vaccine and MTB infected or conditioned
human mesenchymal stem cells to epigenetically program naive human macrophages. Specific Aim-2:
Investigate the in vivo therapeutic and prophylactic effects of conditioned MSCs during experimental
tuberculosis. We will analyze the ability of transfused MSCs to eradicate bacteria and restore lung
function. MSCs have been used in more than 300 clinical transfusion trials to control cancer,
autoimmune diseases and inflammation. We will develop a new method of stem cell therapeutic
vaccination to control MDR-TB.

Public health relevance
Abstract Tuberculosis (TB) kills around 1.5 million people each year and is a major cause of mortality from a single infectious disease worldwide. Emergence of multidrug-resistant TB (MDR-TB) is now a bigger problem in more than 60 countries of the world. MDR-TB not responsive to standard anti- tuberculosis drugs, very difficult to control and as a consequence, shows a high mortality. During the recent years, efforts have been made to strengthen the immune responses in these patients to control tuberculosis organisms. We discovered that human mesenchymal stem cells can strengthen immune cells against tuberculosis. In this proposal, we will develop an innovative and more effective combination of mesenchymal stem cells and an anti-tuberculosis drug to control MDR tuberculosis.